Molecular Analysis of Hindbrain Development

SUMMARY
The extraordinary functional range of the mature CNS requires synchronized activity of neural circuits. Formation
of such circuits involves the timely specification and correct positioning of neural progenitors, and disruptions to
this process are associated with neurodevelopmental disorders. Hence, a key goal of developmental
neurobiology is to understand the control of neural progenitor specification in space and time in embryogenesis.
One mechanism for proper spatiotemporal formation of neural progenitors involves morphogen gradients
that specify distinct progenitor types at different positions. While we know that morphogens do induce
different progenitor types at different positions, we do not understand how individual cells interpret
morphogen signals, nor how they convert this information into distinct cell identities. An informative
example of CNS morphogen action is the developing hindbrain, where retinoic acid (RA) and fibroblast growth
factor (Fgf) control formation of neural compartments (rhombomeres) – each of which represents a unique
progenitor population. However, we do not understand the distinct genetic programs that define individual
rhombomeres, nor how they arise from the earlier hindbrain primordium. Filling these knowledge gaps is
essential, but a profound barrier has been the lack of comprehensive molecular data for individual
progenitors as they undergo specification in response to morphogen signals. We overcame this barrier
by applying scMultiome analysis – which combines RNAseq and ATACseq of individual nuclei – to several stages
of hindbrain development. At the earliest stage, we detect three populations (a.k.a., PHPDs) containing
progenitors with mixed rhombomere (r) identities representing r2/r3, r4 and r5/r6 and we find that these
PHPDs form in response to RA and Fgf. At later stages, our analyses – for the first time – molecularly resolve
all rhombomeres and define their unique gene regulatory networks (GRNs). These advances now allow us
to address several key questions: How do progenitor cells respond to morphogens? How are the mixed
progenitor identities resolved into individual rhombomere identities? How are unique GRNs formed in each
developing rhombomere? We will answer these questions in the context of our hypothesis that morphogens act
via specific cis-regulatory elements to induce mixed identity GRNs in the PHPDs, and these are
subsequently resolved via repressive genetic interactions into rhombomere-specific GRNs that specify
unique progenitor types.
Our project will delineate how morphogens control genetic programs for positioning and specification of
neural progenitors in the hindbrain. Since morphogens control neural specification throughout the developing
CNS, our findings will be broadly applicable to normal brain development, to modeling of neurodevelopmental
disorders, and to the implementation of restorative or replacement strategies as clinical treatments.

Public health relevance
NARRATIVE The proposed experiments are aimed at understanding how different parts of the brain form in the correct place. Brain formation is sensitive to disruptions by a variety of factors (e.g., environmental toxins, infectious agents, and genetic conditions) that give rise to a range of neurodevelopmental disorders – ranging from motor control problems such as ataxia, to cognitive defects such as autism. The results from our experiments will begin explaining the basis of such disorders and will help inform studies aimed at treating them.